An Integrated Device for Rapid Bacteremia Diagnosis Direct from Whole Blood

PROJECT SUMMARY
Leading to over 270,000 deaths in the US annually, septicemia is the systemic inflammatory response to a
bloodstream infection (BSI). Early diagnosis and treatment of BSIs have demonstrated improved patient
outcomes and reduced hospitalization time. However, currently accepted diagnostic approaches have not
advanced substantially since the advent of automated blood culturing systems. As such, today’s gold-standard,
is not only slow, requiring ~1-3 days, but also demonstrates reduced sensitivity in the presence of antimicrobial
treatment. It is therefore critical to advance new diagnostic approaches, which do not rely on culturing.
To address this unmet need, HelixBind developed RaPID/BSI, a fully automated sample-to-answer test which
identifies and characterizes BSIs directly from blood in ~3 hours, without cultures. Implemented on the RaPID
(Resistance and Pathogen IDentification) platform and appropriate for placement throughout the hospital,
RaPID/BSI incorporates a broad test menu of 21 bacterial and fungal pathogens and is not compromised by prior
antimicrobial treatment. Species level detail is provided with single CFUs/ml sensitivity, enabling selection of
appropriate antimicrobials. Commercialization of RaPID/BSI would provide timely characterization of BSIs and
enable intervention with targeted antimicrobial treatment. This would result in improved patient outcomes and
a reduction in the use of unnecessary antimicrobials, slowing the rise of antimicrobial resistance. Reflecting
RaPID/BSI’s significant advantages over exiting alternatives and the potential to improve care and quality of
life, the FDA designated RaPID/BSI a Breakthrough Technology in 2020.
HelixBind has met and exceeded all of the Specific Aims defined in the Phase II SBIR. This included assay
optimization, automation onto a single-use plastic disposable operated by a benchtop instrument, and testing of
clinical specimens. Clinical results demonstrating >94% sensitivity and 99.8% specificity across the assay far
surpassed our milestone of 90% sensitivity and 90% specificity. In addition, based on feedback from potential
customers, the test menu was expanded from 16 to 21 pathogens and the capability to detect resistance
mechanisms was demonstrated.
Given the success of Phase II, HelixBind proposes in Phase IIB to advance RaPID/BSI toward readiness for
regulatory clearance. Specific Aims, each with quantifiable deliverables, serve to address feedback form FDA
received during a Pre-Submission meeting and to de-risk manufacturing and usability aspects of the product.
This proposed Phase IIB will culminate in a blinded, multi-site in-hospital study, challenging our proposed FDA
pivotal study design. Upon completion of this project, we will be well placed to initiate formal Analytical and
Clinical studies for FDA clearance of RaPID/BSI and scale manufacturing for product launch.

Public health relevance
PROJECT NARRATIVE This proposed research effort will advance the development of a novel, fully automated test capable of identifying and characterizing invasive microbial infections directly from blood. Sepsis, the body’s response to these infections, is often life-threatening. Timely administration of appropriate antimicrobials is critical for successfully combating these invasive infections. However, current methods for identifying an infection, necessary to select appropriate treatment, require several days to provide results. Previously, HelixBind has developed and demonstrated a novel turn-key test capable of detecting and identifying these infections within a few hours. Success in this effort will result in the readiness for FDA trials of a low-cost and easy-to-use diagnostic tool capable of providing clinicians with life-saving patient-specific information days faster than currently possible.